Improving Response to Malaria Outbreaks in Amazon-Basin Countries

Abstract
The objective of this proposal is to improve malaria response in the Amazon by enhancing knowledge on when
where, and which targeted interventions will have the greatest impact. There is a critical need for improved
malaria control—since 2011, no region in the world has experienced a larger increase in malaria than the
Amazon. Several events contributed to this rise: extreme weather (i.e., El Nino), expanded resource extraction,
political unrest in Venezuela, and withdrawal of the Global Fund from South America. The unprecedented malaria
resurgence has been particularly high near border regions where migration and poor health care facilitate
transmission. The current surveillance system has a 4-week delay in cases reported, which is completely
inadequate, resulting in reactive vs. preventive intervention strategies. To respond, our team developed a Malaria
Early Warning System (MEWS) with NASA support for Loreto, Peru, where over 90% of malaria cases in Peru
occur. The MEWS forecasts outbreaks with >90% sensitivity and >75% specificity 8-12 weeks in advance in sub-
regions (EcoRegions using unobserved component models [UCM]) and districts (via spatial Bayesian models),
and fits community-based agent based models (ABMs) to evaluate behavioral factors associated with
transmission. However, gaps remain: our MEWS has unknown performance outside of Peru; it does not
incorporate migration; forecasts are not downscaled for hotspot detection; forecasting performance is poor near
border regions; and the models are not integrated across scales. We address these gaps with three aims: (1)
Evaluate MEWS expansion to the Ecuadorian and Brazilian Amazon and evaluate sub-district downscaled
forecasts; (2) Evaluate the relationship between infrastructure, socioeconomic networks, and migration across
international borders with malaria incidence; and (3) Evaluate scenarios of potential malaria interventions along
borders to reduce malaria risk in both countries using ABMs. This project will significantly improve current
surveillance efforts by providing both current estimates and forecasts of malaria using state-of-the-art climate,
hydrology and land cover models. The MEWS is expanded by obtaining surveillance and population data from
Ecuador and Brazil, and merging these with hydro-meteorological data. New EcoRegions that ignore
administrative borders are defined and UCMs are applied. Spatial Bayesian models are used to estimate both
district- and downscaled sub-district level malaria incidence. Infrastructure data are obtained from public sources
and a social network analysis (and data collection) will be conducted in communities along border regions (Brazil-
Peru, Ecuador-Peru). We evaluate malaria incidence along identified network structures up to 300km away from
borders and test simulated intervention scenarios in border communities to evaluate effects on malaria
transmission. This proposal responds to the WHO 2016-2030 Global Technical Strategy for Malaria and the
recent initiatives by the Pan American Health Organization calling for improved malaria surveillance as a core
intervention to improve response to high malaria burden.

Public health relevance
Project Narrative Since 2011, the Amazon has experienced the largest percent increase in malaria cases in the world, with the highest increase in burden occurring in Venezuela, Peru, Brazil, Colombia and Ecuador. Through support from NASA, our team developed a Malaria Early Warning System (MEWS) for Peru that accurately predicts malaria cases 8-12 weeks in advance using sophisticated statistical models and environmental drivers of malaria transmission (i.e., climate, land cover, hydrology). The objective of this proposal is to geographically expand our MEWS to all Amazonian regions and obtain additional data to improve downscaling and forecasting by mapping community networks and potential migration routes related to malaria transmission.